Reducing Misdiagnosis in Alzheimer's Disease: AI-Driven Biomarker Identification

PROJECT SUMMARY /ABSTRACT
Alzheimer's disease (AD) is the sixth leading cause of death in the U.S. and the fifth for adults aged 65 and
older. Projections suggest the number of affected individuals could reach 13.8 million by 2060 without
advancements in diagnostics, prevention, or treatment. AD poses significant challenges in elderly healthcare
due to high misdiagnosis rates and limited early intervention options. Diagnostic accuracy largely depends
on symptomatic assessment, leading to misdiagnosis in up to 25% of cases. Unfortunately, these
misdiagnoses often go unrecognized until postmortem examinations, resulting in inappropriate treatments in
18-67% of cases. These issues create substantial challenges for AD research, including A. Inaccurate
diagnostic labels that undermine research reliability, B. The depletion of patient samples over time, which
restricts research, and C. Timely intervention is crucial for AD, rather than postmortem discoveries.
To address these challenges, reduce misdiagnosis, and facilitate early interventions in Alzheimer's
disease (AD), this project introduces innovative technologies and methodologies with three specific aims:
Aim 1: Construction of a Comprehensive Multidimensional Database. Utilizing SILVER-seq, a
groundbreaking small input liquid volume extracellular RNA sequencing technique, the project will repurpose
over 1,500 limited-volume samples that would otherwise be wasted due to their remaining volume being too
small. This will generate a multidimensional database spanning 25 years of diverse dementia samples,
providing sufficient samples confirmed by the gold standard for subsequent research aims. Aim 2:
Identification and Validation of Crucial exRNA Markers for Precision Diagnosis of AD. By employing
artificial intelligence (AI) technologies, the project will identify crucial extracellular RNA (exRNA) markers for
precise AD diagnosis, significantly reducing misdiagnosis risks. These biomarkers will be integral for
developing protocol and computational pipeline. The project aims to establish an AI-driven gene detection
process to extend practical applications for early intervention diagnostics based on SILVER-seq technology.
The significance of this project lies in its transformative technology and precision diagnosis methods,
aiming to revolutionize AD research and healthcare efficiency. The introduction of SILVER-seq and AI-driven
marker identification represents unique innovations. In conclusion, this project advances AD diagnosis and
early intervention, potentially transforming AD research and healthcare practices.
This training will enable me to complete the proposed studies within three years. It will deepen my
understanding of AD-related diseases, facilitate data generation using novel techniques, and support the
identification and validation of biomarkers. The F32 grant will advance my progress toward becoming an NIH
funded independent investigator, focusing on studying multiple diseases through a genetic lens, with
bioinformatics as the core skill.

Public health relevance
PROJECT NARRATIVE The goal is to reduce the occurrence of misdiagnosis, revolutionize diagnostic accuracy, enable early interventions, and enhance the efficiency of healthcare systems in managing Alzheimer's disease (AD). The core hypothesis of this project is that by leveraging the SILVER-seq technology to process limited-volume scarce samples (often left over from previous studies that are not enough to be used by traditional techniques anymore) and generate extracellular RNA (exRNA) data, it is possible to address critical gaps in AD research. This approach aims to construct a multi-dimensional database, identify crucial exRNA markers for precision diagnosis, and validate robust and reliable biomarkers for future practical applications.